Administrative Core

The administrative support performed in this core is directed to ensuring efficient interactions among the investigators at the three institutions that are involved in the project. In addition to handling subcontracts and serving as a liaison between the Institute's financial office and the other institutions involved, dedicated support is required to ensure coordination of shipments and scheduling essential for the success of the project. The Principal Investigator will have overall and final responsibility for the scientific and financial management of the program and will act in consultation with the project leaders. An Executive Committee involving all Project Leaders and an outside advisor will be formed. The administrative core will provide a structure that provides for regular input from all component programs. The Administrative Core performs all administrative and some secretarial work associated with the program. Included are monitoring timely payments to subgrantees and coordinating activities between the three institutions. An Executive Committee involving all Project Leaders and an outside advisor will be formed. Since this project requires extensive and timely interactions among the different project leaders and their staffs, coordination of shipments of materials, animals and data require administrative attention for smooth functioning.